Genome Editing of Human iPSCs to Study Inherited Hypertrophic Cardiomyopathy

PROJECT SUMMARY
Hypertrophic cardiomyopathy (HCM) affects 1 in 500 people in the general population and is a leading cause
of heart failure and sudden cardiac death. Despite the significant clinical impact and ongoing basic and
translational research, the molecular mechanisms leading to disease onset and progression are poorly
understood. Until now, no specific therapeutic approach has been established. In vitro modeling of
cardiovascular diseases is of high interest as human adult cardiomyocytes are difficult to isolate and propagate
long-term in culture, and animal models have often proven non-predictive of human pathophysiology. Patient-
specific human induced pluripotent stem cell-derived cardiomyocytes (iPSC-CMs) and genome editing
represent novel technologies for modeling cardiomyopathies. In the past funding period, we were able to
recruit ~150 HCM patients. Preliminary data shows diastolic dysfunction and aberrant calcium handling in
iPSC-CMs with mutations in myosin binding protein C3 (MYBPC3). Furthermore, preliminary data shows a
molecular phenotype in MYBPC3 iPSC-CMs characterized by an activation of non-sense mediated decay
(NMD) pathway. However, a major limitation of iPSC-CMs is their immature state as well as the non-
physiological conditions of in vitro assays used so far. Here we propose to increase the significance of
modeling HCM by i) incorporating 2D micropatterned iPSC-CMs and 3D engineered heart tissues (EHTs) to
enhance cellular maturation; by ii) co-culturing iPSC-CMs with iPSC-derived endothelial cells (iPSC-ECs) and
cardiac fibroblasts (iPSC-CFs) in 3D EHTs, and by (iii) using single cell RNA-seq and proteomics approaches
to elucidate molecular mechanisms of HCM cellular crosstalk. Finally, we will evaluate the significance of the
NMD pathway in HCM pathogenesis by using the CRISPR-interference (CRISPRi) and CRISPR-activation
(CRISPa) technology, which allows us to screen expeditiously the functional relevance of inhibition or
activation of a set of genes followed by downstream functional evaluation to localize the target genes with
therapeutic potentials.

Public health relevance
PROJECT NARRATIVE Cardiomyocytes from human induced pluripotent stems cells (iPSC-CMs) are a powerful tool to understand hypertrophic cardiomyopathy (HCM). This study will use genome-edited isogenic iPSC-CMs to investigate the molecular mechanisms on how MYBPC3 mutations lead to disease onset. We will use recent advances in 2D micropatterning and 3D engineering to promote cellular maturation in vitro. We will evaluate cellular crosstalk through co-culture of different iPSC-derived cardiovascular cell types (i.e., cardiomyocytes, endothelial cells, and cardiac fibroblasts) by proteomics and single cell sequencing. Finally, we will evaluate the significance of the non-sense mediated decay (NMD) targeted downstream pathways in the pathogenesis of MYBPC3 HCM, and screen for novel therapeutic targets using CRISPRi/a technology.